Integrating Remote Breath Alcohol Monitoring into Ecological Momentary Assessment of Alcohol-Related Intimate Partner Violence among Young Adult Drinkers

Project Summary
Acute alcohol use and intoxication proximally increase the likelihood of college students’ intimate partner
violence (IPV) perpetration underscoring the need to detect and intervene with alcohol-related IPV during critical
drinking periods. Problematically, retrospective self-reported alcohol use has been the only method used to
assess college students’ alcohol use in relation to IPV perpetration in their natural environment (e.g., ecological
momentary assessment [EMA]). College students’ self-reported alcohol use underestimates their breath alcohol
content (BrAC) by as much as 54% and is fraught with limitations; investigators’ ability to deliver and evaluate
crucially-needed ambulatory alcohol-related IPV interventions (e.g., just-in-time interventions) is hindered by
inaccurate alcohol assessment. Recent advancements in mobile breathalyzer technology allow investigators to
remotely and objectively assess undergraduates’ alcohol use and intoxication in naturalistic settings. When
paired with EMA of IPV, mobile breathalyzers offer a novel approach to strengthening alcohol-related IPV
monitoring; no study has used portable breathalyzers to remotely assess alcohol use in relation to IPV. As a
critical first step toward enhancing remotely-delivered alcohol-related IPV interventions, the overall objective of
the proposed study is to determine the feasibility of using smartphone-linked, portable breathalyzers in
conjunction with smartphone-based EMA to capture alcohol-related IPV episodes and contexts among heavy
drinking college students with a recent IPV history.
We will leverage our team’s established remote alcohol monitoring and EMA procedures to address three aims:
The first aim is to examine the feasibility and acceptability of using portable breathalyzers paired with EMA to
investigate the association between BrAC and IPV among heavy drinking, previously-aggressive college
students. The second aim is to determine if breathalyzer-derived BrAC is a stronger predictor of different forms
of IPV perpetration than is self-reported alcohol use, and whether there are gender differences in these
associations. Our exploratory aim is to examine contexts (e.g., where, when, and with whom one drinks) in
which alcohol-related IPV events occur, which will help optimize EMA delivery in future alcohol-related IPV
studies. Across 30 consecutive days, 100 heavy drinking college students with an IPV perpetration history will
use smartphones to complete 5 daily (1 morning, 4 evening) self-reports of IPV and drinking context;
smartphones will prompt 4 evening BrAC submissions to a smartphone-linked portable breathalyzer (plus event-
triggered reports) to provide the most rigorous, accurate, and ecologically-valid assessment of alcohol-related
IPV to date. Results will provide EMA+ feasibility data to inform a future R01 using EMA+ with a large sample of
couples to identify intra/interpersonal and contextual antecedents of college alcohol-related IPV. Consistent with
the NIAAA’s priorities, the proposed study will enhance methods of tracking alcohol-related IPV in college
students’ natural settings and is an essential first step toward strengthening alcohol-related IPV interventions.

Public health relevance
Project Narrative Alcohol use temporally increases risk for college students’ intimate partner violence (IPV) perpetration, but real-time alcohol-related IPV interventions delivered proximally to drinking episodes remain underdeveloped. As a first step toward our long-term goal of expanding just-in- time alcohol-related IPV interventions, this application will examine the feasibility and utility of objectively monitoring alcohol intoxication in relation to IPV perpetration using portable breathalyzers paired with a smartphone-based ecological momentary assessment application. This objective assessment of alcohol use in heavy drinking college students’ natural environments is a novel shift from collecting self-reported alcohol use data in relation to IPV and will inform the expansion of remotely-delivered alcohol and IPV reduction strategies in real time.